Data Management Core

DATA MANAGEMENT CORE
Abstract
The Data Management Core's continuing mission is to ensure that the Southern and Central
Africa ICEMR effectively and efficiently designs, conducts, analyzes, and reports field and
laboratory studies with data that can be integrated and combined across sites and studies and
shared with local and global partners through the Nchelenge Learning Lab, ClinEpiDB, and
databases for genomic data. To this end, we established an effective and efficient collaborative
environment with an infrastructure for and culture of reproducible research. These successes
are enabled by staff with statistical, database, and information technology (IT) expertise,
empowered by an IT infrastructure based on Research Electronic Data Capture (REDCap), the
REDCap mobile application for mobile data collection, and Open Data Kit (ODK) software that
meets our goals while being attuned to field realities. As part of the Southern Africa ICEMR, we
conduct weekly data management meetings with personnel from all projects and cores, serving
as a forum for multi-disciplinary discussion of data, statistical, and IT issues. We will continue to
conduct these weekly meetings in this ICEMR renewal with the goal of shifting data
management responsibilities and expertise to data management personnel at Macha Research
Trust and the Tropical Diseases Research Centre so these institutions have full capability by the
end of the ICEMR program.